Biological Magnetic Resonance Data Bank

The Biological Magnetic Resonance Data Bank (BMRB) is the unique worldwide resource that provides free
access to the wealth of information on biomolecules derived from nuclear magnetic resonance (NMR)
spectroscopy. As a member of the Worldwide Protein Data Bank (wwPDB), BMRB has close ties with the three
other wwPDB partners: the Research Collaboratory for Structural Bioinformatics (RCSB), the Protein Data Bank
in Europe (PDBe), and the Protein Data Bank of Japan (PDBj). In its role in the wwPDB, BMRB is the designated
archive for all NMR-related experimental data, implementation of standards for NMR data types, and
development and maintenance of software for data deposition and validation. These NMR experimental data
underlie the three-dimensional structures and conformations of many proteins and nucleic acids and provide
important insights into their dynamics, chemical properties, and molecular interactions. NMR is also useful for
characterizing biomolecular interactions, with applications to drug discovery, and in quantifying the components
of complex mixtures of biomolecules, including metabolites and natural products. BMRB maintains an open
architecture and a defined and flexible data model that makes it possible to respond rapidly to changes in
standards for data exchange and to the steady advances in NMR technology (greater variety of archived data
and increasingly detailed associated metadata). Data archived at BMRB include primary data sets (time-domain
data), and derived results such as chemical shifts, peak intensities, scalar couplings, dipolar couplings, and
relaxation and cross-relaxation rates. BMRB integrates these NMR data into a unified, global, molecular
database of general utility to the broad scientific community. The growing volume and diversity of data available
from BMRB are catalyzing transformative scientific applications, such as the determination of protein structure
and dynamics directly from chemical shifts. BMRB and its collaborators develop improved software tools for
integrating the retrieval, analysis, and display of NMR data in the context of molecular structure and
conformation. The funds requested will enable BMRB to streamline operations, enhance sustainability, expand
the diversity and level of coverage of biomolecular NMR data in response to community needs, and improve the
findability, accessibility, interoperability, and reusability (FAIR) aspects of the archive. Operational efficiencies in
verifying, reformatting, archiving, and distribution of new data, and continued productive interaction with users
and creators of biomolecular NMR data is expected to increase the impact of the archive, and to facilitate
collaboration with databanks specializing in related information so that useful connections are established.

Public health relevance
PROJECT NARRATIVE The Biological Magnetic Resonance Data Bank (BMRB) data repository supports the biomedical research efforts of the world wide biomolecular magnetic resonance (MR) community. Magnetic resonance spectroscopy is a key tool used to understand the biomedical significance of protein and nucleic acid structures, to identify potential drug therapeutics, and to characterize metabolites and disease biomarkers.